Development of proprietary bacteriophage Qbeta as a vaccine carrier platform for anti-salmonella vaccine

Project summary
Vaccines have saved millions of lives. However, there are many diseases against which vaccines are not
yet available, with the current COVID-19 pandemic in the world serving as a painful reminder of the need for
vaccines against emerging diseases. With the growing emphasis on vaccine safety, next-generation vaccine
designs have been increasingly focusing on subunit antigens. Because subunit epitopes tend to have lower
immunogenicity, immunogenic carriers are critical to deliver the desired antigen to the immune system and to
enhance the immune responses. However, there are very few carriers available that have been validated in
clinical studies. In this SBIR phase I project, Iaso Therapeutics, Inc. will focus on the development of a proprietary
bacteriophage mutant Qβ (mQβ) virus like particle as a platform technology for conjugate vaccines. In aim 1,
robust protocols will be established for expression, purification, and long-term storage of mQβ. In addition, head
to head comparison will be performed to demonstrate that mQβ can elicit higher levels of antibodies as compared
to current benchmark carriers. In aim 2, the powerful mQβ platform will be applied to deliver Salmonella
associated glycans as potential vaccines against multiple strains of common pathogenic Salmonella. The
vaccine will be optimized to enhance protection from Salmonella infection. When successfully developed, this
project will establish mQβ as an attractive immunogenic carrier for vaccine development and provide important
pre-clinical data for anti-Salmonella vaccines.

Public health relevance
Project narrative Vaccines have had tremendous benefits to our society, saving millions of lives. Immunogenic carriers are critical to boosting the immune responses to conjugate vaccines. In this project, a genetically engineered bacteriophage Qβ will be established as a new vaccine carrier, the power of which will be demonstrated in the development of an effective new anti-Salmonella vaccine.